R-FIX (Rib-FIXation) Spinal Growth System for Early-onset Spinal Deformity

Project Summary
Early-onset spinal deformity is a subset of pediatric spinal deformity that begins before the age of 10 years.
Unlike adolescent idiopathic scoliosis, it is a life-threatening disease, which makes early intervention crucial.
Surgical intervention must accommodate the growth of the developing spine, making this one of the most
challenging orthopedic conditions to treat. Current intra-spinal based treatments, such as growing rods with
pedicle screw fixation, have high complication rates and limited effectiveness. The R-FIX (Rib-FIXation) Spinal
Growth System is an alternative extra-spinal technique that uses rib-based fixation for correcting early-onset
spinal deformity. This extra-spinal rib fixation is a paradigm shift from seeking correction of the spine to
emphasizing correction of thorax malalignment. The R-FIX System originated from a bioengineering lab (one of
the applicants' labs) at Clemson University and has been further developed by Apex Orthopaedic Technologies.
The R-FIX Spinal Growth System has been granted breakthrough device designation by the FDA. The objective
of this SBIR Phase II award is threefold: 1) complete the final design, manufacturing, and quality control
processes for the new R-FIX System components, 2) obtain the necessary biomechanical, biocompatibility, and
sterility data resulting in successful 510(k) clearance of the R-FIX System, and 3) demonstrate the safety and
efficacy of new R-FIX uni-axial rib hook and rib band designs in an animal model. This research will be conducted
over 24 months and the data obtained from this grant proposal will result in a 510(k) application for FDA
clearance and follow-up NIAMS pediatric medical device initiative clinical trial application. Major milestones to
be achieved with this grant include 1) validation of new implantable R-FIX components with surgeon feedback,
2) completion of benchtop performance testing and FDA 510(k) submission, and 3) assessment of the safety
and efficacy of new R-FIX components compared to pedicle screws in a pediatric hyperkyphosis porcine animal
model.

Public health relevance
Project Narrative Early-onset spinal deformity (EOSD) is an important pediatric problem. Currently available forms of surgical treatment fail to support optimal spinal growth and pulmonary development and are plagued by high complication rates. The proposed studies will explore a novel type of instrumentation called R-FIX (Rib-FIXation System) that utilizes rib fixation to correct EOSD.